Dissecting gene regulatory networks and regeneration enhancer elements for zebrafish heart regeneration

PROJECT SUMMARY/ABSTRACT
Adult mammals poorly regenerate injured hearts. In contrast, adult zebrafish possess a remarkable capacity to
regenerate damaged hearts. Combined with available genetic tools, this capacity makes zebrafish a powerful
system for deciphering the innate mechanisms underlying heart regeneration. In the previous funding period,
our laboratory uncovered that interleukin11a (il11a) signaling plays dual roles as a regenerative and fibrotic factor
in adult zebrafish hearts. We demonstrated that these opposite outcomes are caused by cell-type-dependent
effects. By integrating epigenome and transcriptome analyses with transgenic assays, we also identified the
importance of enhancer and promoter pairing in transcriptional activation and cell types emerging in regenerating
hearts and their molecular identity. However, critical gaps remain in our understanding regeneration-associated
genetic and epigenetic mechanisms. First, we know little about transcriptional regulators of il11 signaling
responsible for regenerative processes. Second, while numerous cardiac regeneration enhancers have been
discovered, we still lack a comprehensive understanding of how DNA sequences and their composition encode
regeneration-dependent expression. Third, there is a need to delineate the differences between injury- and
regeneration-associated gene regulatory networks. The current application aims to address these central
questions using cutting-edge genetic and epigenetic analysis tools. We hypothesize that a cardiac mitogen
activates dedicated cardiac regeneration enhancers to initiate the repair process. In Aim 1, we will elucidate
transcription factors (TFs) mediating il11a-triggered cardiomyocyte (CM) proliferation and related gene
regulatory networks (GRNs). Epigenome and biochemical analyses with zebrafish genetic models will identify
the foxm1/e2f8/mybl2b/znf367 complex and their related GRNs as key players for CM proliferation. In Aim 2, we
will define a cluster of cardiac regeneration enhancers (regeneration-cistrome) that ensures precise
transcriptional control of the regeneration response. Our computational analyses with zebrafish transgenic and
regeneration assays will identify enhancer logics of cardiac regeneration enhancers and related cistrome in the
zebrafish genome. In Aim 3, we will employ zebrafish genetic models and CUT&Tag approaches to identify
regeneration-dedicated enhancers to discriminate injury and regeneration processes. Overall, this project will
articulate TF networks and epigenetic factors for heart regeneration, illuminating innate mechanisms promoting
heart repair and uncovering strategies for mammalian heart repair.

Public health relevance
PROJECT NARRATIVE Heart disease is a leading cause of death worldwide, yet effective heart-repair strategies are currently lacking. We propose to define the crucial genetic and epigenetic factors governing heart repair. Our findings will greatly impact our understanding of natural heart regenerative process and the development of innovative strategies to promote heart repair in mammals.